AAOS Musculoskeletal Infection: Where are we in 2014? Research Symposium

Project Summary / Abstract The American Academy of Orthopaedic Surgeons (AAOS) Musculoskeletal Infection: Where Are We In 2014? Research Symposium will provide the musculoskeletal community with evidence-based state of the art knowledge to improve the diagnosis and treatment of musculoskeletal infections, including orthopaedic periprosthetic and post-traumatic/post-surgical infections. The symposium will provide a unique opportunity for collaboration among a multidisciplinary group of orthopaedic surgeons, medical and infectious disease physicians, pathologists, endocrinologists, epidemiologists, health economists and basic science investigators to discuss current research on musculoskeletal surgical site infections as it relates to the musculoskeletal clinicians. Additionally, the symposium will encourage a new generation of musculoskeletal clinician scientists and basic science researchers to collaborate in order to find novel ways to positively impact musculoskeletal surgical site infections by reducing the incidence of these events and improving outcomes once they occur. The specific aims are (1) to assemble and provide a collaborative forum for a multidisciplinary group of clinicians and scientists with a common interest in musculoskeletal infection; (2) to discuss and differentiate the various forms of musculoskeletal infection in terms of microbiology, cellular biology, and pharmacology; (3) to examine and report the state of the art for diagnosing and treating orthopaedic periprosthetic and post-surgical infections; (4) to evaluate and recommend treatment strategies for post-traumatic / post-injury orthopaedic infections; (5) to compare and contrast the disparities that are observed between patient groups in both the development as well as the treatment of musculoskeletal infection; (6) to incorporate evidence based practice guidelines into the diagnosis and treatment of musculoskeletal infections; (7) to report, discuss, and develop consensus statements for the diagnosis and treatment of specialty- specific orthopaedic infections. The outcomes and clinical recommendations from the MI symposium will be disseminated through an article(s) in an orthopaedic journal.

Public health relevance
Project Narrative The AAOS Musculoskeletal Infection: Where Are We In 2014? (MI) research symposium will provide the musculoskeletal community with evidence based state-of the art knowledge to improve the diagnosis and treatment of musculoskeletal infection, including orthopaedic periprosthetic and post-traumatic/post-surgical infections. The MI symposium will differentiate the various forms of musculoskeletal infections in terms of microbiology, cellular biology, and pharmacology, compare disparities observed between affected patient groups, and develop consensus statements for the diagnosis and treatment of specialty specific orthopaedic infections.